Intra- and inter-cluster regulations of multiplex gene clusters

Project Summary
A gene cluster is a group of two or more homologous genes arranged within a certain genomic range. These
gene clusters are widespread in genomes across species. They account for 22% and 18% of annotated genes
in mice and humans, respectively. A gene family usually contains multiple gene clusters located on different
chromosomes. Therefore, studying the regulation of gene clusters adds a new layer on top of traditional tran-
scriptional regulation. Studies on the Keratin, Hox, Globin, Olfactory-Receptor, and other gene clusters revealed
distinct epigenetic and topological states that contribute to differential transcriptional outcomes. The knowledge
gaps in the field are: (i) missing detailed mechanistic machinery that constitutes specific epigenetic and topolog-
ical domains on a gene cluster, (ii) is there general interchromosomal crosstalk of multiplex gene clusters in the
same gene family, and (iii) what protein modules spatially organize gene clusters in the cell nucleus and facilitate
their coordination. The proposed research seeks to decompose (a) epigenetic principles of gene clusters with
distinct expression patterns, (b) molecular mechanisms that configure intra- and inter-cluster conformations, and
(c) protein cascades that organize gene clusters within sub-nuclear structures. We will utilize the multiplex Ker-
atin gene clusters as a paradigm in the biological context of avian skin development. Since gene clusters are
widespread in genomes and used in novel development and organ morphogenesis, misexpression or mutation
of clustered genes contributes to abnormal development and diseases. The proposed research will provide a
fundamental understanding of complex gene regulation. It will also extend our previous insights of localized gene
regulation to how spatial subnuclear compartmentation facilitates transcriptional heterogeneity of compound
genes during tissue development and homeostasis.

Public health relevance
Project Narrative Gene clusters are widespread in genomes but mechanistic understanding of their within-cluster chromatin looping and among-cluster crosstalk is unclear. This study aims to illustrate a stepwise chromatin-protein cas- cade that spatially organizes complex gene clusters from a two-dimensional DNA sequence to a three-dimen- sional subnuclear structure.